NOT-CA-24-111 Improving Strategies for Cancer Reduction through Early-detection and ENgagement (I-SCREEN)

ABSTRACT
This application is submitted in response to the NOSI identified as NOT-CA-24-111. The vision of this CSRN
ACCESS Hub, Improving Strategies for Cancer Reduction through Early-detection and ENgagement (I-
SCREEN), is to leverage existing infrastructure and long-standing collaborations to conduct the Vanguard Study
in diverse clinical settings and diverse populations through close collaborations with the NCI, the CSRN
Coordinating and Communication Center (CCC), the Statistics and Data Management Center (SDMC), and the
other ACCESS Hubs. I-SCREEN Hub has an exceptional opportunity to recruit under-represented populations
to evaluate the two multi-cancer detection blood biomarker tests proposed for the Vanguard Study. We have
selected and engaged health systems in I-SCREEN to include some populations defined by genetic ancestry
(e.g., Hispanic/Latino, Asian, Native Hawaiian/Pacific Islander (NH/PI)), to include rural/frontier populations that
disproportionately represent areas with high poverty and low levels of education, and to include populations with
a spectrum of insurance coverage from uninsured to fully insured. Recruitment populations and sites in the I-
SCREEN Hub include two integrated care delivery systems (Kaiser Permanente Colorado [KPCO] and Kaiser
Permanente Hawaii [KPHI]), one rural health system accepting >25 types of insurance (University Colorado
Hospital-North [UCH-N]), and one rural critical access hospital system (Keefe Memorial Hospital and clinics
[KMH]). Over the past year, the I-SCREEN Hub has worked with the NCI, the CSRN CCC, SDMC, and ACCESS
Hubs, to develop procedures and protocols for the Vanguard Study. These new procedures and protocols differ
substantially from the assumptions used in our original grant application and budget. To successfully execute
the Vanguard Study and achieve our goal of recruiting and enrolling some of the most under-represented
populations in clinical trials, we are requesting supplemental funding through this NOSI. Examples of the drivers
for increased costs include: 1) increased staff time for each participant due to the increased complexity of consent
consistent with the FDA’s Code of Federal Regulations 21 CFR, part 11 compliance which also restricts the use
of anticipated electronic recruitment and consent systems; 2) more in-person/in-clinic recruitment and staff time
for recruitment success due to the timelines and system specific requirements (e.g., OPEN, Medidata Rave) for
participant enrollment and for randomization after the completion of the consent, baseline survey, and blood
draw; and, 3) an increased number of diagnostic evaluations due to a higher predicted MCD test positivity
percentage than originally anticipated. I-SCREEN supplemental funding will ensure the successful completion
of year 2 of the Vanguard Study, will allow us to reach our target recruitment, and will support our goal to recruit
and enroll some of the most under-represented populations in clinical trials.

Public health relevance
NARRATIVE This application is submitted in response to the NOSI identified as NOT-CA-24-111. In close collaboration with the NCI, the CSRN Communication and Coordinating Center, the Statistics and Data Management Center, and the other ACCESS Hubs, procedures and protocols for the Vanguard Study were developed during the first year of funding. These new procedures and protocols differ substantially from the assumptions used in our original grant application and budget. Therefore, we are requesting additional funding to achieve our study goal in the Vanguard Study of recruiting and enrolling some of the most under-represented populations in clinical trials, including Hispanics/Latinos, Native Hawaiian/Pacific Islanders, Asian subgroups, and rural populations.